The role of DNA breaks and repairs in opioid addiction

Abstract
Opioid use disorder is a debilitating disease with a high rate of relapse despite current treatment efforts. Clinical
and preclinical studies have found that opioid-induced chronic changes in gene expression underlie neuroplastic
alterations within the brain reward circuitry, including in the prefrontal cortex (PFC), which lead to the life-long
propensity for relapse. Recent studies highlighted that epigenetic changes orchestrate the opioid abuse-induced
transcriptional plasticity. However, the causes for the epigenome changes and consequent transcriptome
alterations remain unclear.
DNA damage and repair processes play important roles in chromatin integrity relating to proper
epigenetic signature and gene expression in cells. Postmitotic neurons are particularly susceptible to DNA
damage because of their high metabolic and transcriptional output. DNA breaks trigger the DNA damage repair
response, which involves extensive chromatin remodeling to incorporate DNA repair machinery. Therefore, DNA
breaks and repairs can progressively alter chromatin structure to alter gene expression patterns in neurons and,
ultimately, affect behaviors.
Consistent with studies linking DNA damage and opioid addiction, our preliminary data suggest that DNA
breaks are increased in the postmortem PFC tissues from individuals with opioid use disorder and from mice
that self-administered heroin (a valid animal model for opioid addiction). Additionally, the increase in DNA breaks
was accompanied by altered expression of genes that are involved in DNA damage repair. More importantly,
experimentally introducing DNA breaks in the PFC potentiated heroin-seeking behavior in mice. Taken together,
these preliminary data provide evidence that DNA break and repair processes are linked to opioid addiction. Our
goal in this proposal is to identify and characterize the precise role of DNA breaks and repairs in opioid addiction.
Using a unique combination of genomic, epigenomic, and translatomic approaches coupled with affinity
purification, we will fully characterize heroin-induced neuron-specific (PFC parvalbumin interneurons and
pyramidal neurons) alterations in DNA break and repair sites (i.e., the breakome) and the associated changes
in chromatin accessibility (i.e., the epigenome) and gene expression (i.e., the translatome). Additionally, using
CRISPR/Cas9 genome editing approaches, we will identify whether heroin-induced changes in DNA break and
repair sites are directly and causally linked to heroin-induced behavioral plasticity.
This proposal will provide a solid foundation for a wide range of future research endeavors addressing the
genetic and epigenetic mechanisms that underlie opioid-induced long-term transcriptional maladaptation and
ultimately contribute to opioid addiction.

Public health relevance
Project Narrative DNA breaks and repairs have been linked to opioid use disorders. To elucidate the mechanism for this, we propose to characterize the changes in DNA damage and repair sites and the associated changes in chromatin accessibility and gene expression in specific types of neurons in mice that self-administered heroin. Our study will therefore provide a novel mechanism for the epigenetic regulation of the transcriptional and behavioral maladaptations underlying opioid addiction, which will fundamentally advance the understanding of the neurobiology of drug addiction.